Vision Research Training Grant at the University of Utah

Project Summary
With this application, we seek continued support for the Vision Research Training Grant (VRTG)
at the University of Utah. The Vision T32 is currently the only support for trainees seeking
research careers as vision scientists in the Intermountain West. Our interdisciplinary Program in
Vision Science builds on a longstanding track record of excellence in investigations of basic
mechanisms of eye function within the context of human disease that has propelled vision
research at the University of Utah to top national spots in terms of NIH research funding and
ophthalmic clinical care. The Program includes eighteen NIH/NEI- and NSF-funded VRTG
preceptors aligned in five broad areas of vision research (Molecular Biology/Biochemistry,
Cellular and Developmental Science, Ocular Disease/Animal Models, Translational
Interventions, and Computational Science) across five departments, seven interdepartmental
umbrella Programs and the top two research universities in Utah. Funds are requested to train
two predoctoral and one postdoctoral trainee per year in rigorous design, performance and
analysis of experiments, grant writing, effective communication of scientific principles. The
trainees will absorb and present vision-related information through courses, seminars, retreats
and conferences, through meetings with national leaders in vision science and via rigorous,
hypothesis-driven, supervised research. The didactic aspect includes formal RCR,
reproducibility & rigor, statistics, grant writing programs, the Visual Neuroscience course and
other relevant neuroscience, molecular biology, chemistry courses that will equip students with
a comprehensive understanding of basic, applied and in some cases, clinical vision science.
Our pre- and postdoctoral trainees have a superb publishing record, with recent graduates
placed in academic, industry and biomedical positions. The excellent Program outcomes reflect
the high quality of trainees who choose vision science at the University of Utah, dedication and
strong track record of the preceptors, a large affiliate pool of vision researchers and
collaborators, and a rigorous training program that has been put in place over the last 10 years
to train future leaders in vision research.

Public health relevance
Project Narrative Effective treatments of vision loss in 15 million Americans who live with impaired vision will require integration of basic, applied and clinical vision research. The goal of the T32 Vision Training program at the University of Utah is to equip new generations of predoctoral and postdoctoral students with multidisciplinary knowledge and practical expertise to achieve this.